Advancing Research on Mechanisms of Resilience (ARMOR): Prospective Longitudinal Study of Adaptation in New Military Recruits

The RFA for this supplement does not require a project abstract or narrative. However, these two documents are marked as required in the ASSIST application and generate error messages if no documents have been uploaded, thereby preventing the submission of the application. This document has been uploaded to remove the error messages.

Public health relevance
The RFA for this supplement does not require a project abstract or narrative. However, these two documents are marked as required in the ASSIST application and generate error messages if no documents have been uploaded, thereby preventing the submission of the application. This document has been uploaded to remove the error messages.